Pilot Studies of PAX3-FOXO1 Fusions Proteins in Alveolar Rhabdomyosarcoma

PROJECT SUMMARY
The druggable human proteome is vast and yet only a small fraction of it is targeted by current FDA approved
pharmaceuticals. This situation is understandable as the diseases targeted are relatively common and pose
profound burdens in terms of lost years of human life, quality of life prior to mortality, and economic productivity.
Yet there remains a significant ethical and economic need to relieve the burden from rare diseases. To meet this
need, the NIH has released RFA-TR-22-030: Pilot Projects Investigating Understudied Proteins Associated with
Rare Diseases, to which we respond with the current proposal. This pilot project aims to develop biochemical
reagents and assays capable of defining the structure and molecular-scale function of a PAX3-FOXO1
fusion protein that is known to drive the phenotype of the rare disease alveolar rhabdomyosarcoma.
Motivated by our interest in transcription factor transactivation domains, the PI's laboratory has contributed novel
nuclear magnetic resonance spectroscopy techniques that empower high resolution investigation of transcription
factor transactivation domains and their interactions with downstream coregulators, yielding a unique opportunity
to address the unmet need for mechanistic studies of PAX3-FOXO1 fusion protein function that will enable
downstream lead compound screening and eventual drug development. In this context, the first specific aim of
this project is to generation recombinant PAX3-FOXO1 fusion protein constructs and completion of preliminary
structure screening for both the fusion protein's DNA binding region and transactivation domain. Following
screening for solubility and stability, selected constructs will be analyzed through our laboratory's innovative 13C
direct-detect strategy that is uniquely well-suited to analysis of transcription factors and their disordered
transactivation domains. Importantly, the region of FOXO1 included in this fusion is known to be regulated by
lysine acetylation and we have recently developed biochemical and spectroscopic techniques that enable direct
study of these post-translational modifications. The second specific aim is to establish in vitro functional studies
of PAX3-FOXO1 fusion protein interactions with both DNA and protein coregulators. PAX3-FOXO1 interactions
with DNA will be investigated through fluorescence-detected binding assays and targets of opportunity screened
for co-crystallization. Protein-protein interactions mediated by the transactivation domain will be screened using
a combination of sedimentation velocity analytical ultracentrifugation and nuclear magnetic resonance
spectroscopy to identify interactions that may be druggable in future studies. Together, these aims will facilitate
exploration of the relationship between the PAX3-FOXO1 fusion protein and the phenotype of the rare disease
alveolar rhabdomyosarcoma. Ultimately, the in vitro system developed through this pilot study will be leveraged
to define how the PAX3-FOXO1 fusion protein interacts with partners, advance understanding of the molecular
basis for alveolar rhabdomyosarcoma, and set the stage for downstream high-throughput library screening for
lead compounds capable of disrupting interactions mediated by the PAX3-FOXO1 transactivation domain.

Public health relevance
PROJECT NARRATIVE Alveolar rhabdomyosarcoma is a rare disease with poor clinical outcomes for affected patients. In the majority of patients presenting with this disease, the major molecular driver is a chromosomal translocation that creates a novel transcription factor fusing PAX3 and FOXO1, which to date has been severely under-studied at the molecular level. The objective of this pilot project is to develop a biochemical system that will support structural biology and molecular-scale functional assays, such that small molecule screening and establishment of potentially therapeutic compounds can be pursued in the future.